Alcohol and Monocyte Signaling Administrative Supplement

ABSTRACT of the supplement
This administrative supplement is in response to NOSI for Research Supplements to Promote Re-entry, Re-
integration and Re-training in Health-Related Research Careers (NOT-OD-23-170). Specifically, the purpose of
this re-training supplement is to support Marcelle de Carvalho Ribeiro, PhD to return to and advance her research
career after a gap due to family reasons. This is a critical phase in Dr. Ribeiro’s career to gain new research
skills, techniques and concepts that will be instrumental for her future plans to become an independent research
investigator. Experiments proposed in this administrative supplement are fully complementary to those described
in the parent grant without creating any overlap. In this proposal, we will dissect the role of NLRP3 in alcohol-
induced trained immunity. To our knowledge, this a novel research question that is fully aligned with the scope
of the parent RO1. NLRP3, as the mechanistic focus of this supplement, is also highly relevant to the previous
experiences of Dr. Ribeiro on NLRP3 activation and biology. The specific aims of this supplement are: Aim#1:
To evaluate the role of NLRP3 in trained immunity in chronic inflammation and immunosuppression in
alcoholic hepatitis by a) assessing NLRP3 inflammasome activation in trained immunity induced by alcohol; b)
Determining whether NLRP3 is required for alcohol-induced trained immunity in mice, using genetic knockout
models and pharmacological approaches. Aim#2: To target immunometabolic pathways in alcohol trained
macrophages to determine their role in NLRP3 activation by a) elucidating the effects of itaconate on NLRP3
activation and the phenotypic signature associated with trained immunity in alcohol-exposed macrophages and
in mouse model of alcohol induced trained immunity; b) investigating the impact of glutamine metabolism on
NLRP3 activation and the phenotypic characteristics of trained immunity in alcohol-exposed macrophages and
a mouse model of alcohol-induced trained immunity. In Aim 1, the candidate will learn to study trained immunity
in a mouse-model induced by alcohol and new techniques of phospho- and acetyl-proteomics and related
bioinformatic assessment. In Aim 2, Dr. Ribiero will acquire new knowledge about immunometabolism in alcohol
induced trained immunity and learn liquid chromatography-mass spectrometry (LC-MS) metabolomic analysis.
These will be complemented by a rigorous mentoring plan. The scientific scope of this administrative supplement
is fully in line with the scientific goals of the parent grant and promises to gain new knowledge on the role of
NLRP3 inflammasome in alcohol-induced trained immunity and immunometabolic reprogramming.

Public health relevance
NARRTIVE -unchanged from parent application Alcohol use can lead to alcoholic liver disease and it also has inhibitory effects on host defense mechanisms. In this project, we will evaluate a new hypothesis that alcohol use reprograms innate immune cells resulting in inappropriate responses to an infectious challenge, a term called “trained immunity”. We will test this hypothesis by using immune cells from blood of patients with alcohol-associated liver disease and perform mechanistic studies in mouse models of alcohol-induced liver disease first, by identifying epigenetic and metabolic drivers of alcohol-induced trained immunity and second, by testing potential interventions with the aim to restore alcohol- induced immune defects.